Exploratory Pharmcokinetics of UC781 & Tenofovir Vaginal Microbicide Gel V Film

The overarching purpose ofthis Center Grant,

Public health relevance
Success with these aims will describe female genital tract and systemic drug distribution and correlations between drug concentration at the site of action and drug effect, both salutory and toxic. This data will greatly inform decisions regarding future development and clinical study designs to move more efficiently and rationally toward development of a much needed vaginal combination antiretroviral microbicide film.